Determinants of bacterial biofilm formation at the intestinal mucosal interface and their roles in pathogen exclusion

Project Summary
It is well established that biofilms are critical for the pathogenesis of many bacterial infections. More recently,
biofilms have also been implicated in the pathogenesis of intestinal diseases such as colorectal cancer and
inflammatory bowel disease, where mucosal-associated polymicrobial communities harvested from diseased
colon exacerbates disease in animal models. Despite these studies, the presence of biofilms in the intestinal
tract has been controversial. Since the mucus that lines the intestinal tract is constantly shed, the ability of this
layer to provide a stable surface for biofilm formation has been questioned. There are currently no tractable
models to understand or explore biofilm formation in the intestinal environment. As a result, evidence
supporting a role for biofilm formation in colonization of the mucosal surface is lacking. In preliminary data, we
show that deletion of the E. coli gene ntrC (∆ntrC), which encodes a regulator for nitrogen utilization, results in
increased biofilm formation in vitro and confers a 2-3 log competitive advantage over wild-type (WT) E. coli in
vivo in mice (despite reduced growth rate in vitro). These results are consistent with a role for biofilm formation
in intestinal colonization. I therefore hypothesize that competitive fitness of ∆ntrC E. coli is a reflection of biofilm
formation at the mucosal surface of the intestinal tract. The objective is to further characterize the role of
biofilm formation in E. coli colonization of the intestinal tract and to use this model system to understand more
generally the role of biofilms in disease pathogenesis at the intestinal mucosal interface. This hypothesis will
be tested through three inter-related specific aims that will determine the relationship behind biofilm formation
in vitro and spatially-localized colonization throughout the murine small intestine and colon (Aim 1), determine
the role of iron in E. coli biofilm formation and intestinal colonization (Aim 2), and characterize the biological
impact of bacterial biofilm formation in disease pathogenesis using a murine model of colitis (Aim 3). The
experiments will use various innovative approaches including the creation and inoculation of genetically-
modified E. coli strains, quantification of iron via ICP-MS in the intestinal mucus and lumen, and 16S rRNA
gene microbiota sequencing to address these physiologically-relevant mechanisms. The proposed research is
significant because it will provide new information about the bacterial determinants of biofilm formation in the
intestinal tract, with the rationale of using them for competitive niche exclusion in models of colitis. University of
Pennsylvania provides the perfect research environment to conduct this investigation given local expertise in
the inter-related fields of gut microbiome and basic microbiology. The candidate will gain experience in
compositional and functional analysis of the microbiome, acquire fundamental skills in microbial gene
engineering techniques, and broaden her knowledge base of microbiology. These skill sets will greatly
enhance the candidate's career development into an independent scientific investigator, with the long-term
goal of enabling us to better understand and modulate the effects of the gut microbiome in disease states.

Public health relevance
Project Narrative Biofilms have been associated with a number of intestinal diseases such as inflammatory bowel disease and colorectal cancer. I propose further characterize the role of biofilm formation in E. coli colonization of the intestinal tract and to use this model system to understand more generally the role of biofilms in disease pathogenesis at the intestinal mucosal interface. The goal of this project is to develop a deeper understanding of bacterial competition in biofilms and use this knowledge to engineer the mucosally-associated microbiota to modulate intestinal diseases.